Targeting Rad18-dependent replication stress pathways to modulate chemoresponse in BRCA1-deficient cancers

Project Summary/Abstract
Mutations in the breast cancer susceptibility genes BRCA1 and BRCA2 confer an increased lifetime risk of breast
and ovarian cancers. Clinically, BRCA-deficient tumors are sensitive to platinum-based chemotherapeutics and
poly-ADP ribose polymerase inhibitors (PARPi). However, resistance to PARPi presents a challenge for effective
BRCA-deficient cancer treatment. In addition to their established roles in homologous recombination, BRCA
proteins play an emerging role in protecting replication forks from extensive nucleolytic degradation. Stalled or
damaged replication forks reverse their course to aid in the repair of DNA damage, and these reversed replication
forks are the substrates for extensive degradation by nucleases. Notably, extensive nucleolytic degradation of
reversed replication forks is not a terminal event because BRCA-deficient cells activate recovery mechanisms
to cope with extensive degradation. The overall goal of this project is to determine the mechanism of replication
fork recovery in BRCA1-deficient cancer cells, which will contribute to development of novel chemotherapeutic
strategies for BRCA-deficient tumors. My preliminary data implicate the Rad18 protein in the fork recovery
mechanism of BRCA1-deficient cancer cells. Moreover, I found that loss of Rad18 in BRCA1-deficient cancer
cells exacerbates replication fork degradation. Rad18 monoubiquitinates proliferating cellular nuclear antigen
(PCNA), promoting recruitment of Translesion Synthesis (TLS) polymerases to cope with DNA damage. On the
basis of my preliminary data and Rad18’s established ubiquitination activity, I hypothesize that PCNA
monoubiquitination modulates replication fork recovery and plays a novel role in fork protection in BRCA1-
deficient cancer cells. Aim 1 of this proposal will test whether BRCA1-deficient cells activate a Rad18- and PCNA
monoubiquitination-dependent mechanism of replication fork recovery. Furthermore, this aim will determine
whether this mechanism requires specific TLS polymerases to recover the stalled forks. Aim 2 will define how
Rad18 and/or PCNA monoubiquitination mediate replication fork protection. I will use a unique combination of
single-molecule DNA fiber assay and electron microscopy approaches to accomplish Aims 1 and 2. Aim 3 will
test the clinical relevance of exploiting the Rad18 and PCNA ubiquitination pathways therapeutically in BRCA1-
deficient cancers. I will utilize both cultured cell lines and tissue microarrays to test whether Rad18, TLS
polymerases, or PCNA ubiquitination can be effectively targeted to modulate chemoresponse in a BRCA1-
deficient background. The outlined experiments will contribute to novel therapy development, with the ultimate
goal of combating growing chemoresistance in BRCA-deficient tumors.

Public health relevance
Project Narrative Mutations in the breast cancer susceptibility genes BRCA1 and BRCA2 confer an increased lifetime risk of breast and ovarian cancers. This project will determine the mechanisms by which BRCA1-deficient cancer cells respond to chemotherapeutics that perturb DNA replication. By defining potential mechanisms of chemoresistance linked to changes in DNA replication, this project will contribute to the development of novel therapeutics targeting BRCA-deficient tumors.